Mitochondria and TFAM in Osteoblast Biology

ABSTRACT
Once thought to be a mere consequence of the state of the cell, metabolism is now known to play a critical role
in dictating cell differentiation. Non-oxidative glycolysis and oxidative phosphorylation (OxPhos) are the two
sources of intracellular ATP. Factors that increase osteoblast activity and bone mass such as the Hypoxia-
Inducible Factor 1a (HIF1) have been shown to activate non-oxidative glycolysis. In vitro osteogenic
differentiation of mesenchymal progenitors increases both non-oxidative glycolysis and OxPhos. However, the
role of OxPhos in osteoblast biology in vivo is largely unexplored. To fill this gap in knowledge, we generated a
mutant mouse lacking Mitochondrial Transcription Factor A (TFAM) in uncommitted mesenchymal progenitors
and their descendants (PRX;TFAMf/f). TFAM regulates transcription of the mitochondrial genes that encode
thirteen subunits of the electron transport chain and thus controls OxPhos. Analysis of 3-week-old PRX;TFAMf/f
bones revealed the presence of a severe low bone mass phenotype with spontaneous fractures in mutants.
Our data thus indicate that mesenchymal TFAM is necessary for bone mass accrual. In addition, we provided
preliminary evidence that loss of TFAM inhibits the in vitro differentiation of bone marrow stromal cells
(BMSCs) into osteoblasts and significantly reduces their intracellular levels of ATP. Impairment of OxPhos is
the most powerful, consistent and best characterized biological consequence of loss of TFAM across
numerous cell types." " However, TFAM also regulates duplication of mitochondrial DNA, and mitochondria have
functions that go beyond OxPhos and ATP production. Therefore, to establish if the impairment of OxPhos and
thus the decreased intracellular ATP is the primary cause of the PRX;TFAMf/f bone phenotype, we asked
whether correcting the ATP levels through forced upregulation of non-oxidative glycolysis would prevent the
low bone mass of PRX;TFAMf/f mice. For this purpose, we crossed PRX;TFAMf/f mutants with mice
overexpressing a constitutively stabilized HIF1 in the same cells (PRX;HIF1dPAf/f). HIF1 is known to promote
non-oxidative glycolysis and to impair OxPhos.. Preliminary analysis of PRX;TFAMf/f;HIF1dPAf/f double mutant
mice revealed that increased HIF1 activity corrected the bone phenotype of PRX;TFAMf/f mutants. Building on
these findings, we will now test the hypothesis that TFAM in cells of the osteoblast lineage is crucial for bone
mass accrual and maintenance by promoting OxPhos and thus ensuring the proper levels of intracellular ATP.
We will test our hypothesis in three Aims. Progressive impairment of mitochondrial activity has been
associated with numerous aging-related diseases, but it is uncertain whether this association is due, at least in
part, to a dysfunctional OxPhos. The successful accomplishment of the experiments we propose in this
application will expand and deepen our knowledge of the role of energy metabolism, particularly OxPhos, in
the regulation of osteoblast differentiation and bone mass accrual and maintenance.
"

Public health relevance
NARRATIVE If successful, this proposal will significantly advance our knowledge of how glycolytic metabolism controls bone mass accrual and homeostasis. The successful accomplishment of the experimental plan described in this proposal may identify the transcription factor TFAM as a novel regulator of osteoblastogenesis, and this could lead to the discovery of novel therapeutic strategies to increase bone mass.